Macrophage heterogeneity in atrial remodeling

Atrial remodeling, including dilation and fibrosis, can lead to hemodynamic deterioration and atrial fibrillation.
As a consequence, cardiac output declines and atrial clots embolize to the brain, intestines and other organs.
While valve surgery and anticoagulation therapy reduce heart failure and stroke, there are nevertheless
numerous patients who would benefit from a therapy inhibiting atrial remodeling and its consequences. To
address this urgent unmet clinical need, we here propose to investigate the role of macrophages, the fourth
most numerous cardiac cell, in atrial remodeling. In preliminary work for this application, i) we developed and
validated a new mouse model of atrial remodeling that combines key clinical risk factors, ii) we obtained single-
cell RNA-sequencing (scRNA-seq) data from the left atria of mice with atrial remodeling, iii) we determined the
ontogeny of atrial macrophages in the steady state and after atrial remodeling, and iv) we established a
pipeline for scRNA-seq of human left atrial tissues from patients with atrial disease undergoing heart surgery at
MGH. We now propose to test if macrophages form the atria's Achilles' heel promoting atrial remodeling,
fibrosis and atrial fibrillation. We will explore the role of macrophage subsets in atrial remodeling using genetic
and pharmaceutical cell depletion strategies. We hypothesize that during atrial remodeling, disease-promoting
macrophages are derived from blood monocytes while locally sourced macrophages are protective. In these
studies, we will profile structural remodeling of the left atrium by echocardiography, hemodynamic and
electrophysiological studies, histological analysis and FACS followed by real-time qPCR. Our preliminary
scRNA-seq data provide us with a wealth of potential targets to study the causal role of fibrosis-related
macrophage genes in atrial remodeling by loss- and gain-of-function studies. We will test the hypothesis that
gene deletion in bone marrow-derived cells, i.e. recruited macrophage subsets, attenuates atrial fibrosis by
cross-talk to fibroblasts and reduced collagen deposition, leading to less atrial remodeling and reduced
inducibility of atrial fibrillation. In a translational aim, we will study macrophage heterogeneity in human atrial
tissues by scRNA-seq. We will focus on the comparison between human and mouse scRNA-seq data sets
using state-of-the-art computational methods to steer the preclinical discovery work towards pathways that are
important in human disease. Our collaborative application unites an interdisciplinary team with expertise in
immunology, cardiovascular science and computational biology. While the novel research plan is ambitious, we
believe that our preliminary data demonstrate feasibility and provide us with a unique opportunity to study a
question with high clinical relevance.

Public health relevance
We will conduct studies to better understand the function of atrial macrophages in order to advance our long- term translational goal to one day develop macrophage-targeted therapeutics as a new option for atrial remodeling, fibrosis and atrial fibrillation. We will study the role of macrophages in a new mouse model of atrial remodeling that combines clinical risk factors using different cell and gene depletion strategies in combination with single-cell RNA-sequencing. The acquired mouse data will finally undergo rigorous examination for translatability to humans using patient samples.